Physical, Molecular and Cellular Regulation of Sensory Organ Formation

ABSTRACT
During nervous system development, tissues need to move and split to form neuronal cell
clusters and layers. They use attractant gradients for guidance and cellular rearrangement for
splitting. However, how attractant gradients are established and how tissues split in two is
largely unclear. To address these questions, we use the posterior lateral line primordium
migration in zebrafish as a model. The primordium is a group of about 140 cells that migrates
along the body of the embryo and deposits 5–7 mechano-sensory organs called neuromasts
from its back. It expresses the chemokine receptor Cxcr4 and follows a trail of the Cxcl12
chemokine. We have used this system to show that the primordium generates an Cxcl12
gradient across itself by sequestering Cxcl12 in its rear through the alternate Cxcl12 receptor
Cxcr7, a chemokine scavenger receptor, and that the primordium couples actin flow to its
substrate, the basement membrane, through integrins and exerts highest traction stresses
(force per area) in its rear to push itself forward. In Aim 1, we will determine how the
extracellular matrix and the migrating primordium together shape the distribution of Cxcl12a
using an Cxcl12 signaling sensor and knock-in lines that we generated. In Aim 2, we will
analyze the role of RhoA-mediated actomyosin contraction, cell-cell adhesion and cell-
extracellular matrix adhesion in orchestrating the splitting off of neuromasts from the back of the
primordium using cadherin-based tension sensors that we adopted to zebrafish and in vivo
traction force microscopy that we recently developed. Our approach combines the optical
accessibility of the zebrafish primordium with quantitative imaging, embryonic and genetic
manipulations, and sensors for chemokine signaling, RhoA signaling, tension forces and traction
stresses to provide a quantitative understanding of the physical, molecular and cellular
mechanisms underlying tissue guidance and tissue splitting, two key aspects in assemblying the
nervous system. We anticipate that our proposed studies will have two broad impacts on the
field of nervous system development. First, they will provide a quantitative understanding of how
attractant gradients are generated by migrating tissues. Second, they will unravel the mechanics
of tissue splitting. These insights are key to understanding major biological and medical
problems including defects in neuronal development and disease.

Public health relevance
PUBLIC HEALTH RELEVANCE During development neuronal tissues need to migrate and split to assemble the nervous system. We are using a tissue of neuronal progenitor cells in zebrafish as a model to understand how a tissue migrates and splits. These studies will provide a quantitative understanding of tissue migration and splitting, which will inform us how to address medical problems such as neurological disorders.